Transcriptional Control of Mouse FGF23 Expression in Health and Disease

PROJECT SUMMARY/ABSTRACT FGF23 represents a recently discovered phosphaturic hormone whose primary physiological role is to regulate phosphate content in the blood through direct actions in the kidney. FGF23 is expressed in osteoblasts and osteocytes where its output is controlled by phosphate, 1,25(OH)2D3, and PTH. More recent studies now suggest that inflammation and iron deficiency also upregulate FGF23 expression from multiple sources. Despite considerable effort, however, little is known of the mechanisms through which the above regulators modulate FGF23 expression. Using ChIP-seq analysis, we discovered 5 regulatory regions located at distal sites across the mouse FGF23 gene locus that we hypothesized were responsible for FGF23 regulation in vivo. We deleted each of these potential regulatory regions in the mouse genome using CRISPR/Cas9 methods, and have explored their role in mediating the actions of phosphate, 1,25(OH)2D3, PTH and LPS via loss of function studies through these segments in vivo. Our results support a proposal aimed at defining the molecular mechanisms which underlie FGF23 regulation in health and disease. Aim 1: Refine the functional actions and interactions of regulatory enhancers at the FGF23 gene locus that control tissue FGF23 expression in vivo. Several additional strains of regulatory mutant mice will be created using a CRISPR/Cas9 approach and response to phosphate, PTH, 1,25(OH)2D3 and LPS assessed to refine and potentially resolve the genomic sites of action for each of these regulators, and to determine whether regions already identified comprise the entire regulatory domain at the FGF23 locus. These studies will firmly establish the span of functional regulatory activities involved in FGF23 expression. Aim 2: Determine the transcription factors, chromatin regulators and signaling pathways and their interactions that mediate the regulation of FGF23 expression in tissues in vivo. We will use ChIP-seq and ATAC-seq analyses and other techniques to resolve DNA sites of action, enabling the unbiased identification of motifs, transcription factor and chromatin coregulators, and potential signaling pathways that are involved. Aim 3: Identify the temporal role(s) of systemic factors in the regulation of FGF23 expression in an oxalate-induced mouse model of chronic kidney disease. Oxalate-induced acute kidney disease impacts the expression of FGF23 from bone and other tissues. We will examine the ability of oxalate to induce FGF23 expression in tissues as a function of our FGF23 regulatory deletion models. These studies will also focus on assessing the systemic and biological phenotypes that emerge in kidney, skeleton and the vascular system due to amelioration of FGF23 upregulation following oxalate treatment. Our results are likely to provide greater insight into the selective mechanisms through which FGF23 is regulated in vivo in health and disease.

Public health relevance
PROJECT NARRATIVE FGF23 is a phosphaturic hormone that is active in the regulation of mineral homeostasis. While its regulation of phosphate metabolism is crucial to the maintenance of the skeleton and can cause disease, high levels of FGF23 induce additional aberrant effects on the cardiovascular system, the skeletal system and the heart, potentially causing increased morbidity and mortality in humans. The studies herein seek to enhance our understanding of the mechanisms that mediate the regulation of FGF23 with the intent to discover new pathways by which FGF23 expression can be suppressed in pathological states that include chronic kidney disease.